Improving Efficiency, Quality, and Equity: Randomized Controlled Evaluations of Remote vs. In-Person Clinical Trial Methods

PROJECT SUMMARY/ABSTRACT
Remote trials (aka “virtual trials” or “decentralized trials”), in which patients receive treatment and provide
study data without the need to travel to a clinic or medical center, have emerged as a promising approach for
enhancing clinical trial efficiency. However, evidence for the hypothesized benefits of remote trials is weak,
consisting primarily of anecdotal reports, uncontrolled studies, and expert opinion. The same is true for
hypothesized challenges and limitations of remote trials, including concerns about technological barriers and
multiple aspects of trial quality. Clearly, a stronger evidence base is needed to evaluate the impact of remote
trials on the “quality and efficiency of translational research, particularly multisite trials” (CTSA Goal 4).
Randomized controlled trials (RCTs) are the gold standard for comparing treatments – and, by extension, for
testing the impact of remote methods on trial efficiency and quality. Accordingly, we propose an innovative,
rigorous experimental evaluation of remote vs. in-person methods on trial efficiency (accrual) and quality
(retention, treatment adherence, bio-specimen completion rates), across 3 RCTs on 3 different use cases: a
larger, multi-site demonstration trial of pharmacotherapy for smoking cessation at the Buffalo and UPenn hubs
in the UG3 Phase and two smaller, single-site dissemination projects in the UH3 Phase (a mHealth
intervention for people with depressive symptoms at the MUSC hub; an opioid overdose education and
naloxone intervention at the UAB hub). These trials will use a harmonized design and outcomes and follow
participants through 3-month follow-up. Results from these 3 RCTs will be analyzed jointly to assess the degree
to which the findings for remote vs. in-person trial methods generalize across conditions and treatment
modalities. We will also explore whether use of remote versus in-person methods differentially impacts
representation and retention among under-represented groups facing health disparities. The proposed series of
RCTs is significant and novel in its ability to advance our understanding of the impact of remote approaches on
clinical trial efficiency and rigor. The quantitative, qualitative, and cost data generated from this project will
establish a translational science evidence base which will guide the design of future clinical trials. Additional
dissemination efforts (e.g., project website, webinar series, conference presentations, publications, newsletters
and press releases, and a national workshop) will target the CTSA consortium and clinical trialist community at
large.

Public health relevance
PROJECT NARRATIVE Although remote trial designs have emerged as an approach for enhancing clinical trial efficiency and inclusiveness, the evidence base regarding the benefits and limitations of remote trials is weak. The proposed translational science project, a collaboration among four CTSA hubs, will evaluate the impact of remote methods on trial efficiency (accrual) and quality (retention, treatment adherence, bio-specimen completion rates), across 3 different use cases (a larger, multi-site demonstration trial and two smaller, single-site dissemination projects) and will explore the specific impact on under-represented patient groups facing health inequities. The proposed work will be widely disseminated, providing a critical foundation for evidence-based disease- and treatment-agnostic best practices in clinical trial methodology.